PanCorVac (Center for Pan-Coronavirus Vaccine Development)

SUMMARY
Most of the vaccines currently approved or in development against the pandemic SARS-CoV-2 (severe acute
respiratory syndrome coronavirus 2) virus target immunodominant, strain-specific epitopes in the SARS-CoV-2
spike (S) protein and are therefore not expected to confer protection against other coronaviruses. Accordingly,
the NIAID announced NOT-AI-21-002, which calls for the “development of prophylactic vaccines to provide
broad and durable protection against coronaviruses, especially SARS-CoV-2 and others with pandemic
potential”. In response to this call, we assembled the Pan-Coronavirus Vaccine (PanCoVac) consortium to
develop and test novel pan-coronavirus vaccines. Research Project 1 (RP1; Design and evaluation of pan-
CoV vaccines) uses two strategies to develop broadly protective coronavirus vaccines: (i) Focus immune
responses away from the immunodominant epitopes in the head region of S and towards the more conserved,
immune-subdominant epitopes in the stem region of S; and (ii) Refocus immune responses from the variable
immunodominant epitopes towards more conserved epitopes in the head region of S. For each strategy, several
innovative approaches will be used. Novel antigens will be presented by virus-like particles based on a self-
assembling bacteriophage coat protein (a highly immunogenic platform). The candidate vaccines will be tested
for their immunogenicity and protective efficacy against different coronaviruses in an animal model. Selected
candidates will be tested in a second animal model, and with an mRNA lipid nanoparticle platform. Additional
studies will test the durability of immune responses and the effect of vaccination on virus transmission. Samples
from vaccinated animals will be provided to Research Project 2 (RP2; Immunological responses to pan-CoV
vaccines) for a detailed assessment of B- and T-cell responses. First, RP2 will continue its ongoing efforts to
generate and characterize panels of SARS-CoV S-specific mAbs, which will be used in RP1 to help characterize
and prioritize vaccine candidates. Moreover, “Ig-omics”, which involves single-cell technologies allowing high-
throughput analysis of B-cell responses, phenotypes, immunoglobulin (Ig) repertoires and mAbs that react to
several coronaviruses (a technology developed by one of the RP2 investigators), will be used to characterize B
cell-mediated immunity and mAb specificity induced by the candidate vaccines. RP2 will also test (and compare
with data from a human cohort study) the ability of the candidate vaccines to elicit responses to cross-reactive
CD4 and CD8 T cell epitopes. In particular, recently developed novel methods will be used to characterize and
compare the T-cell repertoires upon infection and vaccination. An Administrative Core will oversee and manage
all financial and administrative aspects of the consortium. Our proposed research draws strength from a multi-
institutional team of experts in molecular virology, structural biology, nanobiotechnology, and B- and T-cell
immunology.

Public health relevance
NARRATIVE The global pandemic caused by SARS-CoV-2 demonstrated that public health sectors around the world are not adequately prepared to combat emerging viruses. Given that another zoonotic coronavirus with pandemic potential could cross into the human population, the development of vaccinees with pan-coronavirus efficacy is highly desirable. This project will generate and evaluate pan-coronavirus vaccine candidates based on several novel approaches centered around the spike protein of the virus; therefore, the knowledge gained from the proposed project is directly relevant to NOT-AI-21-002 and the overall mission of the NIH.